Controlled Catalytic Functionalization of Alkenes and Alkynes

Project Summary/Abstract
Fundamentally, a major bottleneck in the drug discovery process across all medical
indications is the difficulty of synthesizing topologically complex small molecules for initial
biological evaluation and ultimately for large-scale production. This, in turn, points back to
limitations in the synthetic toolkit, specifically the paucity of reactions that can be deployed to
rapidly and efficiently synthesize families of structurally intricate compounds from simple starting
materials. In line with the goals of NIHGMS, our research laboratory seeks to address this
problem by developing novel transformations to expedite organic synthesis. Central to our
approach is the use of transition metal catalysts that enable otherwise impossible modes of
bond construction and that facilitate sustainable synthesis consistent with goals of green
chemistry.
Since our laboratory’s inception, we have been motivated by the goal of achieving
“universal functionalization” of carbon–carbon π-bonds, namely the introduction of any two
functional groups desired by an end-user with complete control of regio-, stereo-, and
chemoselectivity. In this way, we endeavor to unlock alkenes, alkynes, and related functional
groups as general progenitors for all functional group combinations needed in synthesis. Our
efforts to date have resulted in the discovery of numerous historically challenging
transformations; the invention of new catalysts, reagents, and ligands that have been
subsequently commercialized; and the development of novel strategies for reaction
development that have been widely adopted within the field.
In the current proposal we seek to continue this positive momentum. The described
projects build on our established platform for reaction development, wherein gaps in synthetic
methodology for π-bond functionalization are targeted, catalyst design principles and
mechanistic insights are extracted, and practical utility and scope are iteratively improved. In the
next five years, we will generate chemical knowledge that that advances the field of π-bond
functionalization and transcends it. First, we will refine and leverage an auxiliary-directed
approach to unlock novel reactivity modes with earth-abundant first-row metal catalysts.
Second, we will develop strategies that obviate auxiliary installation and removal by relying on
interactions with native functional groups. Third, through innovations in ligand design, we will
invent non-directed methods that integrate α-olefins and other unsaturated feedstocks.

Public health relevance
Project Narrative Selective binding of small molecules in a biological milieu derives from structural complexity, and ready access to densely functionalized core structures remains a synthetic challenge. Hence, in order to expedite drug discovery and streamline the entire biomedical research enterprise, there is a pressing need to invent new organic reactions that convert ubiquitous chemical feedstocks into topologically and stereochemically complex products in a single stroke. The goal of this proposal is to fill this gap by developing a suite of novel chemical reactions to achieve selective 1,2-addition of any two functional groups across a carbon–carbon π-bond (alkene, alkyne, etc.) with complete control of regio- and stereochemistry.